Precision Cardiovascular Diseases Phenotyping and Pathophysiological Pathways in the CARRS Cohort (Precision-CARRS)

PROJECT SUMMARY / ABSTRACT (Overall)
Precision-CARRS will revolutionize the cardiovascular disease (CVD) prevention and care paradigm from
imprecise prediction with focus on late stage disease to personalized and precise prediction with improved
understanding of early-stage disease to maintain cardiovascular health. Atherosclerotic CVD (ASCVD) and
heart failure (HF) phenotypes are heterogeneous and result from complex interactions between immutable
genetic factors and mutable forces operating at environmental (e.g., ambient air quality), individual (e.g.,
health behaviors, social influence), and molecular (e, g, proteins, 'omics) levels. South Asians are an
understudied population at high CVD risk even at young ages, at low body weight, and in the absence of
traditional risk factors. We will leverage substantial matched resources, and also build upon the NHLBI-
funded CARRS cohort, a representative sample of n=21,864 South Asians aged ≥ 20 years, with ongoing
follow-up for clinical ASCVD risk factors, clinical disease, and mortality. The cohort has high retention (>95%
have at least one follow-up) and a biorepository of 360,000 stored samples. We will add detailed subclinical
and clinical CVD phenotyping, repeated measures of targeted protein markers and untargeted multi-omics,
and real-time assessment of health behaviors. By extending follow-up by an additional 5 years, we will
accrue 176,536 person-years of follow up, >1,000 incident ASCVD, and nearly >900 cases of clinical HF
(Stages C/D). Enabled by precise mapping of CVD at the granular level of subclinical and clinical
phenotypes, we will investigate the epidemiology and causes of CVD along both ASCVD and HF pathways.
Three complementary cores (Administrative and Field Coordination; CVD Phenotyping; and Data
Management and Analysis) will support four interconnected projects, one of which is led by an early-stage
investigator (ESI). All four project examine common subclinical and clinical endpoints from synergistic vantage
points: traditional risk factors and targeted protein-based pathophysiological pathways (Project 1), the impact
of air pollution and mediating mechanisms (Project 2), molecular signals and mechanisms through integrative
untargeted multi-omics (Project 3), and socio-behavioral influences on CVD risk and outcomes studied via
spousal dyads (Project 4, ESI). Precision-CARRS will unravel the natural history, pathophysiology, and
causal factors of vascular and myocardial disease and pave the way for precision CVD diagnostics,
prevention, and care for South Asians–who represent one fifth of humanity and are a rapidly growing sub-
population in the US. In summary, Precision-CARRS is designed to be a powerful platform to understand the
natural history of CVD in an understudied high-risk population and to spur future innovative scientific
collaborations with other CVD longitudinal cohorts in the US and globally.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Precision-CARRS seeks to transform the way we predict, prevent, and treat heart disease, stroke, and heart failure, from identifying late stage disease to earlier disease, that may be different across groups of people. We will leverage the NHLBI-funded CARRS Cohort of 21,864 adult South Asians, a population at high risk for heart disease even at young ages and who might not have obvious reasons to develop heart disease, stroke, and heart failure. Our proposed research program includes inter-connected studies that will help us understand how factors that lead to heart attacks and heart failure develop in different people and will drive a revolution of finding unique factors in people that can be targeted with suitable prevention and care strategies.